Per- and Polyfluoroalkyl Substances (PFAS) in Marine Fish and Shellfish: A biomonitoring tool for PFAS remediation and a metric for potential human exposure through seafood consumption

Abstract included in Research Strategy per FOA

Public health relevance
NARRATIVE The hiring of a Research Technician, Nathan Giffard, of an underrepresented racial group will allow the accomplishment of two new related aims for the parent R21 entitled, "Per- and Polyfluoroalkyl Substances (PFAS) in Marine Fish and Shellfish: A biomonitoring tool for PFAS remediation and a metric for potential human exposure through seafood consumption." The new related aims will allow for the enhancement of the investigation of the PFAS contamination and exposure in Great Bay NH associated with Pease Air Force Base, for the hired the Research Technician to gain research experience in interdisciplinary environmental health research, and will enhance the diversity of Dartmouth College which is located in Northern New England, a region where minority representation is among the lowest in the country.